CLINICAL STUDIES MONITORING SERVICE (CSMS), NATIONAL CENTER FOR COMPLEMENTARY AND INTEGRATIVE HEALTH (NCCIH; POP: 08/31/2016 - 07/31/2020)

CLINICAL STUDIES MONITORING SERVICE (CSMS), NATIONAL CENTER FOR COMPLEMENTARY AND INTEGRATIVE HEALTH. This is a monitoring contract that performs quality assurance on NCCIH-funded extramural clinical trials in integrative health.